Elucidating the Role of Neuropilin-1 in Intratumoral Regualtory T Cell Stability

? DESCRIPTION (provided by applicant): The adaptive immune system serves to eliminate pathogens while sparing host tissue. The efficiency of this system is largely dependent on balance; unrestrained immunity can cause autoimmunity while a slow or absent response can lead to chronic infection and cancer. Regulatory T cells (Tregs) play a critical role in maintainin this balance through the suppression of self-reactive immune responses. Treg stability is crucial to maintain effective suppressive capacity. Neuropilin-1 (Nrp1), a surface receptor has emerged as an important mediator of Treg stability. Nrp1 binds the ligand, Semaphorin-4a (Sema-4a), leading to enhanced Treg stability intratumorally. In the absence of Nrp1:Sema4a ligation, Tregs lose stability and suppressive capabilities, leading to enhanced anti-tumor immunity and reduced tumor growth. The fate and function of Nrp1-deficient Tregs is unclear. This research proposal suggests experiments that will propel our understanding of how Nrp1 alters Treg stability, and will elucidate the molecular mechanisms leading to a distinct Treg cell population and reduced tumor growth. Understanding these mechanisms is of crucial importance in understanding tumor immunology, and in creating new targets for immunotherapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Regulatory T cells are essential for providing balance to the immune system. These cells provide protection against autoimmune diseases; however, they also prevent successful anti-cancer immunity. Our research seeks to understand how regulatory T cells are stabilized in the tumor microenvironment, and how the lack of stability affects the fat and function of regulatory T cells in cancer.